Structural and functional characterization of glycosyltransferases in the Campylobacter concisus N-linked glycoconjugate biosynthetic pathway

Bacterial glycoconjugates are a diverse group of macromolecules that play a key role in bacterial survival and
pathogenicity by mediating bacteria-host interactions. Despite their structural diversity, many glycoconjugates
are made by prokaryotes utilizing a common mechanism, which includes transferring glycans to a Pren-PP-
linked carrier at the membrane interface. The striking diversity of glycoconjugates is achieved through sequential
addition of glycans by glycosyltransferases (GTs), which transfer sugars from soluble nucleotide-activated
donors (NDP-sugars) to the lipid-based carrier molecule. Despite being ubiquitous across all kingdoms of life,
GTs still represent an excellent target for antibiotics, due to the remarkable degree of selectivity they exhibit for
structurally very similar sugars. Understanding the structural features that influence GT substrate selectivity and
protein-protein interactions in pathogenic bacteria like Campylobacter species is critical for antibiotic
development, and this research proposal strives to address that knowledge gap. To date, the substrates for C.
jejuni GTs have been confirmed in the Campylobacter genus, but structural information for PglA, PglJ, PglH1,
and PglH2 of C. concisus, another clinically significant human pathogen, is still unavailable. Additionally,
characterizing GTs from the same organism's glycoconjugate biosynthetic pathway will offer the structural
information needed for future protein-protein interaction studies and will pave the way for analysis to clarify how
these proteins interact to modulate pathway flux. Aim 1 of this proposal will identify preferred GT substrates
using nano-differential scanning fluorimetry (nanoDSF) and determine steady-state kinetic parameters using
luminescence-based GT activity assays. Aim 2 will be to discover the detergent and buffer conditions required
for crystallization of purified GTs, as well as to optimize protein crystals and collect X-ray crystal data to obtain
high-resolution crystal structures. Aim 3 will be to characterize a number of orthologs from a GT-B sequence
similarity network (SSN) in order to gain insight into GT evolution and to pinpoint the primary sequence variables
that account for their various substrate specificities. Interprotein covariance between GT residues will be
investigated via the GREMLIN method in order to identify interactions responsible for the hypothesized formation
of supramolecular complexes between these enzymes. The resulting findings will reveal binding determinants
controlling specificity for glycans prevalent in pathogenic prokaryotes and demonstrate crucial structure-function
links and protein-protein interactions.

Public health relevance
Antibiotic-resistant bacteria continue to emerge in the human population, reducing treatment options for patients, and prompting researchers to look for novel bacterial targets in order to develop effective treatments. Glycosyltransferases (GTs) are enzymes that are responsible for diversifying the glycan portion of bacterial glycoconjugates, which are essential for bacterial viability and pathogenicity, and represent a viable antibiotic target. The proposed biochemical and biophysical methods will determine structural factors that can be used to determine which glycans GTs act upon and how best to direct therapeutics against them.